BEHAVIORAL MANIFESTATIONS OF PAIN IN POSTANESTHESIA CARE UNIT PATIENTS

This CLINFO ONLY project analyzed the data obtained from the Chambers and Price Rating Scale adapted to measure the relationship between behavioral manifestations and self-report of pain in PACU patients.